Second generation GLP-1 agonists without nausea/emesis side effects

Project Summary
The proposed research of this R01 application focuses on creating a second-generation glucagon-like peptide-
1 (GLP-1)-based pharmaceutical that retains all of the blood glucose lowering profiles but completely eliminates
the major side effects of nausea, vomiting and malaise. Such side effects, along with hypophagia, are produced
by existing GLP-1R agonists due to central nervous system (CNS) penetrance and direct action in the brain.
Thus, we sought to create GLP-1R agonists with reduced brain penetrance but with the full potent
pharmacodynamic profile on pancreatic GLP-1R populations. Our novel preliminary data convincingly
demonstrate the ability of a vitamin B12 (B12) conjugate of the GLP1-R agonist Exendin-4 (Ex4), namely (B12-
Ex4), to produce hypoglycemia in a glucose tolerance test (GTT) in both mouse and rat models without producing
hypophagia or nausea/malaise. This glucoregulation without nausea/malaise appears to be due to a virtual
absence of ligand penetrance into the CNS, a hypothesis supported by radiolabelled B12 studies showing
extremely low levels of B12 entry into the brain, as well as immunohistochemical analyses of fluorescently-
tagged B12-Ex4 in comparison to native Ex4 at the site of CNS activation. This application therefore tests the
following specific aims to both enhance the preclinical assessment of B12-Ex4 as a second-generation T2DM
therapeutic and test the hypothesis that the total portfolio of therapeutic effects that exploit the `B12-family' can
be enhanced by conjugation of Ex4 to a fragment of B12, specifically cobinamide (Cbi), which targets Haptocorrin
(HC), a Cbi binding protein found only in mammals, including humans: [1] Characterizes the physiological,
behavioral and anatomical mechanisms mediating the hypoglycemic effects of B12-Ex4 without the incidence of
hypophagia and nausea/malaise using both lean/euglycemic and obese/hyperglycemic rat and mouse models;
[2] Conducts systematic in vitro and in vivo analyses of a novel Cbi-Ex4 compound for glucoregulation without
eliciting nausea/emesis or competing with endogenous B12 transport in the musk shrew which both is capable
of emesis and expresses HC, like the human, but unlike the mouse and rat. The compounds described herein
also offer scope to investigate, through relatively simple experimentation, the role of CNS versus periphery in
the function of GLP-1R agonists in animals and humans. As such they have significant potential as investigative
research probes in addition to their clear potential as a new generation of therapeutics. Most notably, these
highly innovative experiments will provide the necessary pre-clinical analyses for the B12- and/or Cbi-based
conjugates of Ex4. Such studies will lead to significantly improved, clinically beneficial, second generation
therapeutics for the treatment of T2DM without the most common nausea/malaise side effects of existing GLP-
1-based therapeutics, which will improve patient quality of life, patient compliance to therapy, and expand the
population that can benefit from the amazing improved glycemic profile achieved with GLP-1R agonists.

Public health relevance
Relevance: Project summary: Relevance to public health. As Type II Diabetes Mellitus rates continue to reach epidemic proportions, driving health and economic costs higher, the need to find safe, effective, and economically achievable therapies for the treatment of this disease is ever increasing. For this reason, much attention has been devoted to investigating pharmacological drugs based on the hormone GLP-1 for diabetes treatment, as it lowers blood glucose concentrations. Unfortunately, nausea and vomiting are the major side effects of all GLP-1-based drugs on the market, with ~25% of patients unable to tolerate effective doses. Novel research proposed here fully analyzes the effects of chemical attachment of vitamin B12 with an FDA approved GLP-1 based drug, the result of which is the complete elimination of all nausea and vomiting side effects, but retention of the desired blood glucose lowering profile – in essence creating a new second generation of improved GLP-1 therapeutics for diabetes treatment, which improves patient quality of life and expands the population that can benefit from such important therapies.